Data Science COre

DATA SCIENCE CORE: ABSTRACT
The purpose of the Data Science Core (DSC) is to provide professional expertise in biostatistics, bioinformatics
and research informatics for all SARS-CoV-2 Serological Sciences Centers of Excellence (U54) projects,
investigators and participants. Functions provided by this core include development of experimental designs and
power and sample size analysis; database development, data quality control; statistical and bioinformatic analysis
and interpretation of findings; and collaboration on presentation of results. To achieve these functions, the core
director, Dr Yu Shyr, and core members, Drs. Lynne Berry, Qi Liu and Emanuela Taioli, are constantly available to
investigators and are in regular contact with project and core leaders.
The primary objectives of the DSC are:
1. To provide study design and review all laboratory, animal and translational studies including feasibility
assessment, power and sample size analysis.
2. To collaborate in project data analysis, interpretation of results and the writing of final study reports and
manuscripts.
3. To work with the Clinical Core in the development of research project databases to maintain data quality control
and to ensure timely data capture.
4. To develop and evaluate statistical/bioinformatic methods for experimental design and data analysis.
DSC support is required in all U54 studies. Core personnel have worked and will continue to work closely with
project leaders to ensure the core provides state-of-the-art statistical, bioinformatic and research informatic
support as needed.